Develop and Validate a Mouse Model for Alzheimer Disease in Down Syndrome

Alzheimer disease (AD) exacts enormous personal and financial burdens in the aging. People with Down syndrome (DS) (i.e., trisomy 21, HSA21) are at markedly increased risk of AD, a disorder called DS-AD. The clinical and pathological hallmarks of AD are replicated in AD-DS. More than 80% of those living beyond age 65 are diagnosed with DS-AD. The emergence of DS-AD is thus essentially inevitable in the DS elderly and serves as the leading cause of death. DS-AD thus constitutes the largest population in which a genetic lesion causes AD. An important insight into DS-AD is that increased dose of the gene for APP, present on HSA21, is necessary. Findings in mouse models of DS-AD concur, demonstrating a necessary role for increased APP dose and expression for DS-AD neurodegenerative phenotypes. Studies of DS-AD mouse models have provided important insights, but no current model captures all the pathological features of DS-AD. Three important missing features are: amyloid plaques, congophilic angiopathy, and neurofibrillary tangles (NFTs). We propose to develop and validate a DS-AD model to capture these phenotypes. We will genetically modify the TcMAC21 mouse. This mouse carries an essentially full copy of HSA21 in addition to two copies of homologous mouse chromosomes. To replicate DS-AD amyloid pathology we will humanize the Aβ sequence in mouse APP by crossing with mice in which the Aβ peptide sequence in mouse APP has been humanized, thus conferring a human pattern for processing with increases in APP-C99 and its Aβ products. To introduce human-like tau pathology, including NFTs, the resulting mouse (TcMAC21:APP/hu/hu/hu) will be crossed with mice deleted for mouse tau that express a transgene encoding wild type human Tau. In addition to amyloid and tau pathology we predict the genetically modified TcMAC21 mice will replicate key DS-AD phenotypes. Our hypothesis is that the TcMAC21 mouse will model key pathological features and age-related changes in molecular, cellular and circuit function characteristic of DS-AD. In the R61 Phase: Specific Aim 1 (Project Years 1-3), we will demonstrate feasibility and scale of use, and internally validate it by documenting measures of molecular, cellular, and synaptic age-related phenotypes characteristic of DS-AD with rigor, precision, reliability, and sensitivity, and dependence on APP gene dose. Go/NoGo criteria must be satisfied for moving to the R33 Phase: Specific Aim 2 (Project Years 4,5) in which we will externally validate, through demonstrations of : face validity: 1) measures of cognition; 2) clinical biomarkers, including Aβ42, Aβ40, p-tau species and NFL; construct validity: 1) presence and structure of amyloid plaques and congophilic angiopathy; 2) aggregates of phosphorylated tau; 3) neuroinflammation, including changes in microglia and astrocytes; 4) deficits in synapse number and function; 5) neuron loss; and 6) transcriptomic/genomic signatures; and predictive validity: 1) demonstrate that reducing APP gene copy number prevents/reverses DS-AD linked signatures; and 2) show that clinically feasible interventions prevent and/or reverse DS-AD phenotypes. A valid model will accelerate the ability to understand and treat DS-AD.

Public health relevance
Those with Down syndrome (DS) are at markedly increased risk for Alzheimer disease (AD); this disorder is referred to as DS-AD. Studies in animal models of DS-AD have provided important insights into pathogenesis and have phenocopied many DS-AD features. Importantly, as for DS-AD, increased APP gene dose is necessary for DS-AD-related phenotypes in models. Nevertheless, existing models fail to demonstrate the amyloid plaques, congophilic angiopathy and tau pathology of DS-AD. Given the importance of these lesions we propose to create them by genetically modifying the TcMAC21 model of DS through humanizing the Aβ sequence in mouse APP and introducing a wild type of human Tau transgene. We will seek internal validation in Aim 1 and external validation in Aim 2. Go/NoGo criteria for internal validation in Aim 1 and milestones for both Aims are defined. Our hypothesis is that genetically modified TcMAC21 mice will prove to be a fully valid of DS-AD to support studies of DS-AD pathogenesis and treatment.